Mechanistic studies of ABC importers in pathogenic bacteria

PROJECT SUMMARY
This proposal seeks to understand how proteins located in the cell membrane work as gatekeepers to
selectively allow compounds into or out of the cell. Such gatekeepers are known as or ATP-binding
cassette (ABC) transporters, because they use the energy of ATP (adenosine triphosphate) hydrolysis
to transport compounds across the cell membrane. Bacterial ABC importers are essential for organism
survival, controlling the rate of uptake for nutrients scavenged from the bacterium’s environment.
Control of the rate of transport precludes over-accumulation of a nutrient that is beneficial at low
concentrations but is potentially toxic at high concentrations. While a subset of ABC proteins contains
an additional “accessory” domain that can regulate the uptake of compounds by shutting off the
transporter, it is unclear why certain transporters contain these domains while others do not. However,
we do understand that certain transporters are “turned off” when a specific compound or protein binds
to this accessory domain. Other accessory domains regulate by “sensing” changes in the
microenvironment and reacting accordingly. To decipher this mechanism of regulation, the PI’s
laboratory combines biochemical and biophysical experiments with structural biology to understand how
both the overall architecture and transport mechanism restricts or allows nutrients to enter the cell. This
research program will define the molecular mechanism that controls nutrient uptake and allow
researchers to understand how multiple transport systems work in concert within an organism to
maintain cell survival. With a focus on a broad range of ABC transporters that recognize diverse
substrates and fit into the two classes (Type I/Type II), we will continue to examine how topology and
selectivity are the driving forces in virulence. This research program has set out to close critical gaps in
the understanding of the fundamentals of the transport mechanism present in all bacteria. The results
will yield insights into how regulatory domains modulate transport across all organisms, crucial for cell
v iability .

Public health relevance
Project Narrative The objective of this research program is to explore the mechanisms by which pathogenic bacteria employ ABC transporters to acquire essential nutrients while mitigating cellular toxicity. Through the utilization of biophysical and biochemical techniques, we aim elucidate the complex mechanisms governing substrate selection and transport including the various conformational states that facilitate the passage of substrates across the lipid biolayer via the translocation pathway using ATP hydrolysis. Comprehensive studies on Type I and II transport systems linked to virulence will shed light on selectivity and autoinhibition, which will undoubtedly advance the field on the therapeutic f ront.